Single cell, genome wide dissection of dynamic transcription factor regulation

PROJECT SUMMARY
Despite having limited sets of signaling components and number of genes, cells must be able to distinctly
respond to a large number of input signals, such as environmental stresses, as well as execute diverse gene
expression programs. It is vital that cells receive, transmit, filter, and act upon these signals accurately to trigger
the appropriate downstream gene response program, as dysregulation and aberrant signaling have important
implications in the initiation or progression of diseases such as immune disorders and cancer.
Specifically, a single transcription factor (TF) can respond to a wide variety of input signals by changing its
nuclear localization dynamics to activate specific promoters. However, the study of transcriptional dynamics is
limited to largely correlational relationships due to technical barriers such as cell-to-cell variability, pleotropic
effects of experimental perturbations, expression averages that mask heterogeneity, and fluorescence based
techniques that limit the number of measurable target genes. The central hypothesis of this work is that the
functional connections between TF dynamics and their downstream regulation of gene expression
programs can be identified and tuned by the integrated use of carefully characterized and controlled
optogenetic systems with single cell RNA sequencing (scRNAseq), increasing our understanding of
gene regulation in human cells for engineering and biomedical applications. NF-κB (p65/RELA), which
regulates hundreds of genes and is heavily implicated in immunological responses and cancer, will serve as the
model TF for our system.
To address this challenge and information gap, the proposed work will build upon a suite of sophisticated
tools developed in our lab to combine optogenetic based TF translocation with scRNAseq. We will establish a
robust, tightly controlled system and examine the genome wide effect of direct perturbations of NF-κB across
thousands of cells. Three main objectives will be targeted: Aim 1 will result in the development of a fully
controllable, optogenetic system to precisely regulate p65 translocation in HeLa cells by landing pad integration,
optimization of localization dynamics, and validation by reverse transcription quantitative polymerase chain
reaction of known target genes. Aim 2 will focus on determination of whole-genome gene transcriptomic profiles
and cell-to-cell heterogeneity in response to traditionally used, chemically stimulated p65 dynamics using
scRNAseq. By combining these two components, Aim 3 will directly control p65 dynamics with 15 distinct
optogenetic inputs and assess resultant single cell transcriptomic changes using scRNAseq. In sum, we aim to
provide an efficient, functional system to provide direct, causal relationships between TF dynamics and
gene expression in human cells and exact control in cellular engineering by leveraging complete control
of TF translocation through optogenetics, precise tools in mammalian synthetic biology, and transcriptome wide,
single cell gene expression profiles provided by scRNAseq.

Public health relevance
PROJECT NARRATIVE Transcription factors (TFs) regulate gene expression responses to a variety of input signals; and ensuring accurate transmission of this information remains an important challenge in understanding disease progression as dysregulation can lead to autoimmune disorders or cancer. TF p65/RELA regulates hundreds of genes in the NF-κB pathway, including those implicated in inflammation and tumor suppression. Here, we will develop a precisely regulated, optogenetic, single cell, and genome-wide approach to comprehensively characterize dynamic regulation by NF-kB, providing a new platform to gather fundamental knowledge of gene regulation in human cells for downstream applications in therapeutics and biomedical engineering.